Administrative Core

Project Summary
The Administrative Core at the Cancer Prevention-Interception against MGUS Progression
(CAP-MGUS) Center will provide administrative, scientific, fiscal, and logistic oversight over the whole
Center. The Core will also provide clerical support, coordinate interactions between the Bioinformatics Core
and Research Projects, and organize regular investigator meetings inside and outside the CAP-MGUS Center.
It will bridge the research activities within the CAP-MGUS Center and the NCI CAP-IT program officials to
promote collaboration, ensure that the CAP-MGUS Center’s work contributes effectively to issues relevant to
the CAP-IT mandates, and maximize dissemination and application of Center discoveries. The Administrative
Core has five primary objectives. First, the Core will manage and communicate the research activities within
the CAP-MGUS Center. Second, the Administrative Core will promote collaborations on MGUS prevention and
interception between the Research Projects and the Bioinformatics Core within the CAP-MGUS Center and
collaborations between the Center members and outside investigators. Third, the Administrative Core will
organize annual meetings and other network activities. Fourth, the Administrative Core will conduct effective
and contextually appropriate outreach. Fifth, the Administrative Core will evaluate existing Research Projects
and develop new ones. The CAP-MGUS Center will be one of the few national research consortium centers
dedicated to both IgM-MGUS and non-IgM MGUS prevention and interception. The Administrative Core will
bring together top experts in MGUS and related cancers and other blood disorders, provide scientific and
logistic oversight to Center activities, disseminate scientific knowledge and discoveries, and liaise between
Center members and outside stakeholders.